Deep Learning Based Phenotyping and Outcomes Prediction for Valvular Heart Disease

ABSTRACT
Mitral valve disease is a common underrecognized disorder affecting over 170 million individuals worldwide,
however a sizable proportion of individuals will experience adverse myocardial response leading to degenerative
mitral regurgitation, heart failure, cardiac arrest, or even sudden cardiac death. Myocardial remodeling
responding to mitral regurgitation can lead to changes in cardiovascular structure and function, but general
patterns of change during early disease (such as diastolic dysfunction and increased sphericity) are insufficient
to distinguish between appropriate compensated myocardial response to innocent mitral valve prolapse vs. early
manifestations of future symptomatic degenerative mitral regurgitation associated with adverse outcomes.
Recent advances in artificial intelligence (AI), when applied to biomedical images, indicate that deep learning
algorithms can both offer precise measurements beyond human fidelity and also identify subtle traits in imaging
that are unrecognized by the human eye. Our prior work applying AI to echocardiography as well as others
applying AI to other forms of medical imaging, have shown deep learning can not only reproduce standard
measures of cardiac structural and function but is also identify CVD risk features including chronologic age,
biological sex, diabetes, hypertension, and smoking. In effect, AI applied to echocardiography now offers the
potential to capture a precise phenotyping of mitral valve disease, characterize myocardial response, aggregate
risk of future comorbidity and, in turn, identify intervenable target for mitigating future CVD risk. Thus, we
hypothesize that AI methods applied to echocardiography can be used to not only precisely characteristics mitral
valve disease by (i) automating the phenotyping of mitral regurgitation severity, systolic dysfunction, diastolic
parameters, and other measures of adverse myocardial response that demonstrate trajectories of accelerated
versus delayed cardiovascular risk, (ii) discern key contributors to accelerated cardiovascular risk in mitral valve
disease, and (iii) be used on large clinical cohorts to identify clinical underdiagnosis. To test these hypotheses,
we will leverage echocardiography images that are acquired as a part of routine clinical care in addition to serial
imaging frequently obtained in large cohort studies of aging adults. Because healthcare cohorts are enriched for
patients with accelerated and high risk trajectories, while epidemiologic cohorts are enriched for individuals with
delayed and low risk trajectories, we plan to analyze imaging and outcomes data collected from both types of
cohorts. Accordingly, our aims are to train and validate AI models on phenotyping mitral valve disease from
cardiac imaging and identify its component contributors to excess cardiovascular risk in both the healthcare
setting and in the community setting.

Public health relevance
PROJECT NARRATIVE Mitral valve disease is often under-recognized and not well characterized in echocardiography, the most common form of cardiac imaging. Artificial intelligence has the potential to identify subtle phenotypes, often not recognized by human clinicians, and distinguish between stable asymptomatic incidental findings and high-risk features that can lead to sudden cardiac death and other adverse outcomes. We will leverage deep learning applied to cardiovascular imaging to capture key features of mitral valve disease that could represent intervenable targets for mitigating cardiovascular risk.